A stem cell-based model of the human muscle spindle for studying proprioceptive dysfunction in distal arthrogryposis syndromes

PROJECT SUMMARY
Distal arthrogryposis (DA) syndromes are a collection of congenital disorders characterized by joint contractures
and orofacial dysmorphisms. The most common genetic cause of DA phenotypes are autosomal dominant
missense mutations in the MYH3 gene, encoding the embryonic myosin heavy chain. It has been suggested that
expression of mutant MYH3 within contractile muscle fibers is responsible for the developmental defects that
characterize DA pathology. However, the contribution of intrafusal fibers to the etiology of DA phenotypes has
not yet been investigated. Intrafusal fibers are specialized cells of the muscle spindle; a proprioceptive structure
responsible for regulating contractile activity in response to stretch. Since rapid tissue growth during
embryogenesis leads to dynamic changes in mechanical cues throughout the organism, it seems logical to
assume that defects in spindle function could severely impact the ability for the musculature to respond correctly
to these signals. This, coupled with the fact that MYH3 expression persists in intrafusal fibers past embryonic
stages of development, highlight the importance of studying the contribution of intrafusal fibers to DA pathology.
One of the reasons that intrafusal fibers have not been studied in relation to DA syndromes is the scarcity of
spindle structures in normal muscle. Only about 50,000 spindles are present in the entire human musculature,
making in extremely unlikely that one will be present within a given biopsy sample. To overcome this issue, we
will utilize induced pluripotent stem cells (iPSCs) to produce human intrafusal fibers with both normal and MYH3
mutant genotypes. In Aim 1, optimization of these cells from iPSCs will be performed using primary rodent tissue
as a benchmark for spindle morphology. Optimized iPSC-derived spindle cells will then be subjected to controlled
stretch to quantify their activation in response to mechanical cues and to characterize any functional differences
that arise between mutant and control cells. As it is not yet known whether mechano-sensitive ion channels are
present in the intrafusal fiber membrane or in the membrane of associated sensory neurons (or both), these
experiments will be conducted in isolation and in co-culture with type 1a sensory neurons. In Aim 2, iPSC-derived
intrafusal fibers will be subjected to single cell RNA sequencing to characterize the transcriptome of MYH3
mutant and normal spindle cells and identify whether the expression of mutant MYH3 contributes to an altered
phenotype that persists to later stages of development. Again, primary rodent cells will be used to establish a
benchmark transcriptomic signature for spindle cell types. Results from iPSC-derived intrafusal cells will be
compared to those obtained from mutant and wild type extrafusal (contractile) muscle fibers to determine whether
the transcriptomic impact of mutant MYH3 is more pronounced in the spindle than in the surrounding cells of the
musculature. Overall, this project will increase our understanding of intrafusal fiber biology, provide a new in vitro
assay for probing spindle function, and help determine whether mutant intrafusal fibers contribute to DA etiology.

Public health relevance
PROJECT NARRATIVE This project seeks to elucidate the role of intrafusal fibers (specialized skeletal muscle cells that regulate contraction in response to stretch) in contributing to distal arthrogryposis syndromes that arise from mutations in developmental muscle proteins. To do so, we will establish a novel screening platform with which to observe the interaction of human stem cell-derived intrafusal fibers with sensory neurons and quantify their functional interaction in response to stretch. We will then use single cell genetic analysis to investigate what impact distal arthrogryposis-related mutations have on the development of cultured human stem cell-derived intrafusal fibers and how this compares with that of normal, contractile extrafusal fibers.